Signaling Mechanisms Regulating Rho GTPase-Dependent Synaptic Plasticity Underlying Memory in Health and Disease

PROJECT SUMMARY
The ability to remember and the capacity to forget are both required for a functional memory system, whereas
their dysfunction is a common feature of cognitive disorders such as Alzheimer’s Disease (AD). It is unclear,
however, how these opposing memory processes are balanced. Memory formation is driven by activity-
dependent synaptic changes in neurons involved in the memory trace. Rho GTPases regulate this synaptic
plasticity by controlling actin dynamics. Although Rac1 and RhoA can promote learning and memory, Rac1 also
plays a key role in forgetting. To function properly, Rho GTPases require precise spatiotemporal regulation that
is mediated by guanine nucleotide exchange factors (GEFs) and GTPase-activating proteins (GAPs), which not
only control Rho GTPase activity, but also provide signaling specificity via interactions with upstream receptors
and downstream effectors. We previously identified the Rac1-GEF Tiam1 as a critical regulator of spine/synapse
development that couples synaptic receptors like NMDAR and EphB2 to localized Rac1-dependent actin
remodeling. Tiam1 forms a GEF/GAP complex with the Rac1-GAP/RhoA-GEF Bcr, which bidirectionally
regulates excitatory synapse development by dynamically controlling synaptic Rac1 activity. Following Bcr loss,
excessive EphB-induced Tiam1-Rac1 signaling drives EphB internalization and spine retraction rather than
synaptogenesis. However, the role of this GEF/GAP complex in the adult brain remains unclear. Using Tiam1
conditional knockout mice, we recently found that Tiam1 restricts NMDAR function and synaptic plasticity in the
dentate gyrus of adult mice and limits learning and memory, in contrast to Bcr. Thus, we hypothesize that Tiam1
and Bcr cooperate in the adult brain to provide spatiotemporal control and signaling specificity to Rho GTPases,
enabling dynamic regulation of synaptic plasticity critical for learning, memory, and forgetting. Moreover, Ab-
induced Tiam1-Rac1 dysregulation likely drives aberrant synaptic plasticity that contributes to AD-associated
memory impairments, and targeting this pathway will alleviate these deficits. To test this hypothesis, we aim to:
(1) uncover the mechanisms by which Tiam1/Bcr dynamically regulate Rho GTPase signaling and synaptic
plasticity important for learning and memory; (2) determine how Tiam1/Bcr regulates hippocampal-dependent
learning, memory, and forgetting in adult mice; and (3) elucidate the role of Tiam1-Rac1 in Ab-induced
EphB/NMDAR internalization and synapse loss, and determine how targeting this pathway affects synaptic
plasticity and learning and memory deficits in an AD mouse model. We will accomplish this using a combination
of mouse genetics, viral injections, confocal imaging, biochemistry, pharmacology, electrophysiology, and
behavioral analyses. Our study should provide critical insight into Rho GTPase-dependent mechanisms that
control normal synaptic plasticity underlying learning, memory, and forgetting as well as Ab-induced synaptic
dysfunction. Furthermore, it will establish whether targeting Tiam1-Rac1 signaling rescues synaptic plasticity and
memory deficits in an AD mouse model, which may aid in the development of a new therapeutic strategy for AD.

Public health relevance
NARRARIVE We propose to investigate the mechanisms that regulate how synaptic connections in the brain remodel during processes like learning, memory and forgetting in healthy brains and in a mouse model of Alzheimer’s disease (AD). We will study a fundamental signaling transduction pathway that is implicated in a wide variety of human brain disorders including AD, intellectual disabilities, autism spectrum disorder, schizophrenia, and depression. Results from our study will enhance our understanding of key mechanisms that control synaptic plasticity underlying learning and memory, and it will provide critical mechanistic insight into AD-associated synaptic dysfunction and memory deficits, which may aid in the development of novel therapeutic strategy for AD.